Examining Time and Nutrient Dependent Effects of Aerobic Exercise on Energy Metabolism in Adults with Overweight and Obesity

PROJECT SUMMARY & ABSTRACT
Does time of day of exercise and nutrient status prior to exercise affect the 24-hour (h) metabolic response? The
objective of this proposal is to determine the effect of aerobic exercise performed in the morning (AM) or evening
(PM) under fasted and fed conditions on 24h energy expenditure (EE), substrate oxidation, hormonal profiles,
and key metabolites in adults with overweight and obesity. Nearly two-thirds of US adults who attempt to lose
weight engage in exercise as a primary strategy. However, weight loss from exercise alone is highly variable
and less than predicted. Thus, strategies to enhance weight and fat loss from aerobic exercise are desperately
needed. Two promising strategies that may help to promote fat loss are exercising in the morning and exercising
while fasted. Our preliminary data, as well as others’ data, suggest that morning exercise promotes greater fat
loss, and this enhanced fat loss may be due to increased EE and fat oxidation. Further, engaging in aerobic
exercise in the post-absorptive state (fasted) has been shown to increase fat oxidation, free fatty acid
mobilization, transient energy deficit, and β-hydroxybutyrate concentration compared to post-prandial (fed)
exercise. These clinical data are supported by several recent preclinical studies delineating the energetic
responses to AM vs. PM exercise in rodent models. Importantly, AM exercise favors fatty acid and amino acid
metabolism while PM exercise enriches glycolytic pathways. One limitation of these preclinical investigations is
that nutrient status prior to exercise (fasted vs. fed) was not controlled and evaluated. Nutrient status affects
subsequent energy metabolism with fasted exercise promoting glycogen depletion and fatty acid mobilization.
Therefore, fasted AM exercise may be the optimal treatment paradigm for promoting fat loss. However, a
rigorously controlled study examining the effect of both exercise timing and nutrient status during exercise on
24h energy metabolism is needed. In the proposed study, adults with overweight or obesity will complete a
baseline, no-exercise control visit, followed by 4 exercise conditions (Fasted-AM, Fed-AM, Fasted-PM, Fed-
PM) in a randomized order, separated by a 2-5 week washout period. Each condition will include an acclimation
period, eucaloric and macronutrient-controlled diet, and control of physical activity, sleep, and meal timing. This
study will measure 24h components of EE and substrate oxidation using whole-room indirect calorimetry (Aim
1) and untargeted and targeted plasma metabolites and hormonal/energy profiles (Aim 2). Plasma metabolites
and hormonal/energy profiles will be examined using serial blood draws immediately following exercise every 1-
2h across the 24h in-patient visit. The central hypothesis is that fasted AM exercise will result in the most robust
metabolic response that is optimal for fat and weight loss followed by Fasted-PM, Fed-AM, Fed-PM, respectively.
The study is significant as it could identify a practicable strategy to enhance weight and fat loss. Further, findings
from this study could identify the “optimal metabolic response” for exercise treatment of other metabolic diseases.

Public health relevance
PROJECT NARRATIVE Given the popularity of exercise as a weight loss strategy, and exercise’s limited success at eliciting weight loss, it is important to rigorously identify and evaluate strategies that improve weight loss from exercise. Morning exercise and fasted exercise have been touted as beneficial strategies for increasing fat loss, yet limited evidence supports these claims. The proposed research is relevant to public health because it will provide a robust dataset regarding the impact of morning versus evening exercise and nutrient status (fed vs. fasted) on 24h energy metabolism regulation which will inform future interventions focused on enhancing fat loss from exercise.